Macromolecular Recognition in Coagulation

Project 1 Abstract
We employ the prothrombinase complex, its substrate, prothrombin and its product thrombin as paradigms for
the enzyme complexes, zymogens, substrates and cofactors of coagulation to investigate generalizable
features establishing the molecular bases for their function. An emphasis is placed on addressing major
unanswered questions relating to allostery or how interactions or ligand binding to one site can affect function
at distant sites by combining biophysical studies with structural and functional measurements based on a
foundation of established mechanism to provide new mechanistic insights. The first aim extends previous
observations that despite irreversible cleavage of prothrombin to yield thrombin, the proteinase can exist in an
equilibrium between zymogen-like and proteinase-like states. We extend these findings in a direct
thermodynamic approach to understand how ligand binding at exosite 1 favors proteinase-like forms and
exactly counteracts liganding at exosite 2 on the opposite face of the molecule. The second aim expands to
mechanisms related to allosteric changes in factor Xa using a class of small molecules with previously unseen
behavior; they inhibit Xa function in solution but become poor and partial inhibitors of Xa when it is
incorporated into prothrombinase. Kinetic studies combined with structural work will seek to establish the
mechanisms underlying the putative allosteric modulation of Xa by this class of molecules. The third aim seeks
to provide an ultimate functional test of how proteolytic activation of factor V imparts Xa binding and cofactor
function by disrupting a tripartite inhibitory motif comprising two acidic regions (AR1 and AR2) flanking the B
domain interact with a centrally located basic region (BR). We propose to identify tight binding nanobody
probes to AR2 and BR. Probes that destabilize or stabilize the inhibitory structure are proposed to allow
cofactor function without proteolysis or prevent the development of factor function after proteolysis. The last
aim extends studies to factors IXa and VIII/VIIIa of intrinsic Xase to address peculiarities that set the proteinase
and cofactor of this complex apart from those of prothrombinase. With IXa, we pursue structural evidence that
suggests that the proteinase may distribute between forms with a distorted and open active site. In factor VIII,
we focus on a thrombin cleavage site at the junction of the A1 and A2 domains, that is essential for cofactor
activation but without a counterpart in factor V. We pursue the hypothesis that loss of cofactor function
associated with the removal of the cleavage site can be rescued by the insertion of a polypeptide spacer to
mimic the putative repositioning of the A1 and A2 domains that might follow cleavage. These strategies,
utilizing novel concepts, are all directed towards how ligand binding or other effects modulate conformation and
dictate function. The proposed approaches will shed new light on important yet poorly understood facets of the
biochemistry and biology of enzyme function relevant to normal hemostasis, in disease states and for
therapeutic targeting of reactions in thrombotic and vascular disease.

Public health relevance
Project 1 Narrative Excessive blood clotting is a major cause of heart attacks and strokes in the United States and also underlies ~25% of cancer-related death. Our research brings new concepts and methodologies to bear on understanding basic molecular mechanisms underlying the blood clotting reactions. Our findings will address important but unresolved aspects of function to yield novel strategies for interfering with the formation of life-threatening blood clots in human disease.